2022 National Conference on Interstate Milk Shipments

2022 NCIMS Project Summary
The National Conference on Interstate Milk Shipments (NCIMS) requests
scientific conference grant funds for the amount of $50,000.00 for the 38th
National Conference on Interstate Milk Shipments scheduled to be held April 7-
12, 2022 at the J. W. Marriott hotel in Indianapolis, Indiana. The funds would be
used by the NCIMS in the following manner:
Travel Support for State Delegates: $25,000 would be used to support travel
expenses for the state voting delegates who would not otherwise be able to
attend the conference.
Conference Services: $25,000 would be used to help offset conference
expenses for items that are allowable under the grant. These expenses include
rental of audio visual equipment that is needed to facilitate ease of viewing
computerized projection of work documents and hearing critical debate on the
proposals being considered by the members of the Committees, Councils, voting
state delegates, FDA officials, and conference attendees. Funds will also be
used to record conference proceedings and debate during voting on proposals by
a hired court reporter. Remaining funds will be used towards printing of the
conference program and materials.
Due to extraordinary circumstances of the COVID pandemic the NCIMS
conference that would have been held in 2021 was postponed until 2022. This
left the NCIMS with a dire shortfall of operating income during 2021 and into
2022. Therefore, applying funds from scientific conference grant to help offset
conference service and expenses will provide need revenue for continued future
operation of the NCIMS. It is also anticipated that due to COVID that conference
registration will be considerably lower than previous years generating less
income to cover conference expenses.

Public health relevance
2022 NCIMS Project Narritive The NCIMS is applying for a $50,000.00 grant of which $25,000 would be used by the NCIMS to support travel expenses for the state voting delegates who would not otherwise be able to attend and $25,000 for conference services including, but not limited to, recording the proceedings, audio visual equipment rentals, publication costs to print conference proposals for the 38th National Conference on Interstate Milk Shipments scheduled to be held April 7-12, 2022 at the J. W. Marriott hotel in Indianapolis, Indiana. These funds are needed to to help offset conference expenses and provide revenue for continued future operation of the NCIMS.